Targeting MicroRNAs to Eradicate Leukemia Stem Cells

PROJECT SUMMARY
Leukemia stem cells (LSCs) are at the apex of the acute myeloid leukemia (AML) cellular hierarchy. The
quiescent fraction of LSCs provides a reservoir of self-renewing cells that sustain leukemia growth, prevent clonal
exhaustion, and are treatment resistant; thus, eliminating LSCs is the `holy grail' of any anti-leukemia treatment.
In previous studies, we showed that miR-126 is necessary to maintain a quiescent subfraction of LSCs that
prevent clonal exhaustion. We demonstrated how SPRED1/miR-126 autoregulatory loop in LSCs and in BM
endothelial cells (ECs) converge to increase miR-126 levels in LSCs, protect them and support leukemia growth.
We showed that high miR-126 levels are due to both LSC autonomous mechanisms, resulting in enhanced
endogenous production, and non-autonomous mechanisms, through exogenous miR-126 supply from ECs.
To deplete miR-126 in LSCs and ECs, we designed a novel oligodeoxynucleotide anti-miR-126 inhibitor, called
miRisten. Our data show that pharmacological miR-126 deprivation by miRisten significantly decreases LSC
endogenous production of miR-126 and decreases the exogenous supply of endothelial miR-126. The net result
is a significant decrease of miR-126 that damages the homeostasis and activity of LSCs, as demonstrated in
serial transplant experiments. In addition, we now have evidence that miR-126 enhances mitochondrial
metabolism (i.e., oxidative phosphorylation) and mitochondrial dynamics (i.e., mitochondrial fusion) in LSCs
through SPRED1/ERK/p-BCL-2/NRF2 signaling. Accordingly, depletion of miR-126 by miRisten treatment
significantly downregulates BCL-2 and disrupts mitochondrial metabolism, leading to increased levels of reactive
oxygen species and apoptosis of LSCs. In addition, miRisten disrupts LSC mitochondrial function by upregulating
the dynamin related protein 1 (DRP1), inducing mitochondrial fission, decreasing mitochondrial membrane
potential, and inducing expression of mitophagy marker proteins. Since mitochondria-centered metabolism is
the main metabolic energetic source for LSCs, we propose to dissect how miRisten exploits the mitochondrial
metabolic vulnerability as a novel mechanism of action to eliminate LSCs. Furthermore, after conducting
Investigational New Drug application (IND)-enabling pharmacokinetic, pharmacodynamic and toxicology studies,
we will rapidly translate miRisten from bench to beside with a first-in-human phase 1 clinical trial of miRisten in
patients with relapsed/refractory (r/r) AML. The central hypothesis of this proposal is that miRisten targets miR-
126-depended metabolic vulnerability of LSCs and will provide a novel therapeutic approach for LSC elimination
in AML. We propose the following Specific Aims (SAs): SA#1: Determine the mechanisms of miRisten-induced
mitochondrial metabolic vulnerability in LSCs. SA#2: Conduct pharmacokinetic, pharmacodynamic, efficacy
and toxicology studies of miRisten to inform dose and schedule selection for human studies. SA#3: Conduct
a first-in-human phase 1 trial of miRisten in patients with r/r AML. This project will translate novel discoveries on
miR-126 into the clinic, by conducting preclincal studies that culminate in a first-in-human trial of miRisten.

Public health relevance
Project Narrative: Acute myeloid leukemia (AML) patients have a poor five-year survival (<30%), likely due to the persistence of a very resistant leukemic cell population called leukemia stem cells (LSCs). We identified a small RNA molecule called miR-126 as a potential target in LSCs and have invented and produced a miR-126 inhibitor called miRisten to eliminate the otherwise treatment-resistant AML LSCs. We are planning to test this new compound by conducting mechanistic, pharmacokinetic, pharmacodynamic and toxicology studies followed by a phase 1 clinical trial in AML patients with resistant disease.